Research Education and Training Core

Abstract: Research Education Core (REC)
The goal of the Chicago Asian RCMAR – Research and Education Core (REC) is to increase the number of
successful interdisciplinary researchers from underrepresented populations prepared to conduct translational
trauma and resilience research focusing on Asian American older adults. The Center in conjunction with the
REC will provide an enriched environment that develops Scholars who: 1) understand the biological, social-
cultural, psychological, and behavioral sciences with a specific emphasis on knowledge about mechanisms of
action underlying trauma and related outcomes at the individual or population level, focusing on Asian elders;
and 2) can conduct innovative pilot research that forms the basis for future minority aging research, ultimately
designed to improve the lives of older persons and the capacity of institutions to adapt to the needs of our
graying society.
To achieve this goal, the REC will be fully coordinated with the Administrative Core and accomplish these
specific aims: 1) Build research capacity of a diverse group of scholars focused on translational trauma and
resilience research and collaborative efforts with established research scientists; 2) Mentor and train RCMAR
scholars in a nurturing, collaborative, and interdisciplinary environment that encourages scholar development
in collaboration with colleagues and mentors; 3) Solicit and select up to 20 scholars over 5 years to conduct
mechanistic, behavioral, and social aspects of trauma and resilience research; 4) Track and evaluate success
of Scholars to develop new lines of research using an iterative evaluation process; and 5) Build institutional
sustainability so this RCMAR training supports partnerships and creates a pipeline of new and continued
research to build the science and practice of trauma-informed care.
To achieve the successful Scholar development and related successful, innovative pilot research, the REC
will implement a 2-year training program with these inter-related components: Formal Training, Pilot
Grant/Publication Skills, Grantsmanship Skills, and a Community/Health Policy Experience. The 2-year training
program, which will contain the 1-year pilot project, will: 1) allow our RCMAR Scholars the time to not only
learn interconnected content that is relevant to their own pilot but also to the broader field; 2) increase
structured mentored time to hone career development, grantsmanship, and manuscript skills; and 3) increase
the professional, peer, and community partner networks to which Scholars are connected. Such elements of
our training program are tailored to our REC leader's decades-long experience mentoring minority and
underrepresented trainees and faculty across the science workforce pipeline. A final innovative aspect of our
REC and Center is that we have assembled and made available one of the largest repositories of large
datasets on Asian populations health outcomes for scholar pilot research.

Public health relevance
Project Narrative: Research Education Core Aging research suffers from a lack of diversity both in populations-studied and investigators who conduct research. The field of trauma and resilience research is significantly underdeveloped, and demographic shifts in the U.S. population reveal a need to examine aging issues in historically underserved, and exponentially growing, populations, particularly Asian older adults. Immigrant populations, particularly those from Asian countries, experience high levels of trauma yet hold varying levels of resilience which impact health outcomes. Our Chicago Asian RCMAR aims to address this lack of research focus and the workforce to conduct such research both on U.S. Asian populations and especially older adults.